Developing and validating race-specific cardiomyopathy risk prediction models in African American survivors of childhood cancer

Survivors of childhood cancer treated with anthracycline chemotherapy or chest-directed radiation are at
substantially increased risk for developing cardiomyopathy that progresses to heart failure (HF). Compared to
the general population, survivors have a 15-fold greater risk of HF and 7-fold excess risk of death due to
cardiovascular (CV) causes. Within this vulnerable clinical population, African American (AA) survivors face a
disproportionate burden of cardiac morbidity and mortality, largely driven by the higher burden of potentiating
CV risk factors and cardiomyopathy. In our recent work, we found the prevalence of cardiomyopathy was 2.5-
times higher among AA survivors than Non-Hispanic Whites (NHWs). However, existing survivor-directed HF
risk prediction models are not race-specific. Given effective strategies to identify/detect cardiomyopathy and
prevent HF in survivors are likely to differ by race/ethnicity, we hypothesize that novel race-specific
cardiomyopathy risk prediction models developed and validated exclusively in AA survivor cohorts will
significantly enhance clinical risk stratification in this population. Using data from the St. Jude Lifetime Cohort
(SJLIFE) with up to 1,200 AA survivors that is unprecedented in terms of its size and extent of clinical
characterization, we propose to: (a) perform a first-of-its-kind analysis to systematically identify influential
predictors and develop (“train”) new cardiomyopathy risk algorithms in 700 AA survivors with existing deep
clinical annotation from direct, in-person assessment and whole-genome/-exome sequencing data; and (b)
validate (“test”) these novel risk models in independent SJLIFE AA survivor data (N~481). Our specific aims are
to: (1) develop and independently validate clinical risk prediction models for cardiomyopathy for AA survivors
considering primary cancer treatments and conventional CV risk factors, followed by incremental model-building
to include informative cardiac biomarker, lifestyle risk, and personal-/area-/policy-level social determinants of
health (SDOH) predictors; (2) identify genetic predictors for cardiomyopathy and evaluate their added
contributions to clinical risk prediction; and (3) contextualize the performance of these novel models, including a
generalizability assessment in existing independent data from AA survivors in multi-institutional studies (N=349)
and comparative analyses considering published/validated HF risk models. Along with a race-specific study
design, key innovations of our approach include the comprehensive assessment of predictors that have not been
evaluated previously in survivor HF risk prediction models (e.g., cardiac biomarkers; personal-/area-/policy-level
SDOH) and novel utilization of genetic data that can potentially maximize cardiomyopathy risk prediction,
including genetic analyses of echocardiographic parameters predictive of cardiomyopathy and the development
of polygenic risk scores that capture genetic susceptibility for treatment-related cardiomyopathy risk. Ultimately,
achieving these aims have the potential to advance precision survivorship care while contributing to efforts to
reduce racial/ethnic disparities in cardiac-related morbidity/mortality among childhood cancer survivors.

Public health relevance
PROJECT NARRATIVE Survivors of childhood cancer treated with anthracycline chemotherapy or chest-directed radiation are at substantially increased risk for developing cardiomyopathy that progresses to heart failure (HF), but this risk is disproportionately higher (2.5-fold) in African American (AA) survivors than Non-Hispanic Whites (NHWs). There is an urgent need to address this disparity by formulating novel solutions that support effective cardiovascular follow-up care for AA survivors. Leveraging the world’s largest sample of AA survivors of childhood cancer with exceptional clinical and genetic (next-generation sequencing) data, we propose to address this need by: (1) developing and independently validating race-specific clinical risk prediction models for cardiomyopathy; (2) identifying and assessing novel genetic cardiomyopathy predictors; and (3) contextualizing the performance of newly developed race-specific risk algorithms through extensive generalizability and comparative analyses, critically informing future efforts to integrate race-specific cardiomyopathy prediction models into survivorship care clinical workflows.